Decision Making Challenges and Needs for Health Insurance Exchange Enrollees

PROJECT SUMMARY/ABSTRACT Navigating health insurance options is daunting, particularly for consumers who must purchase coverage on their own in the non-group market. Much is at stake in these decisions, which determine not only the adequacy of financial risk protection but may also have important consequences for health care access and health, especially for vulnerable populations. Health insurance exchanges can facilitate plan selection by creating a marketplace to choose among qualified health plans and by providing decision support tools to help consumers optimize their choices. The goal of the proposed project is to understand the downstream experiences of enrollees in the non-group market after choosing a plan, and to identify those at highest risk for adverse outcomes so that strategies can be developed to address their needs. The project’s specific aims are to: 1) examine how exchange enrollees differ from those who enroll in non-group plans outside the exchange in terms of socioeconomic and clinical characteristics, decision support tools used, and type of plan chosen; 2) explore whether use of particular tools during enrollment in non-group exchange and non-exchange plans is associated with type of plan chosen and better downstream health care outcomes (e.g. avoiding delayed/forgone care and financial burden due to out-of-pocket costs, and being able to continue to see one’s prior provider); 3) identify enrollees who prove to be at highest risk for adverse downstream outcomes in non- group plans using characteristics that can be measured at enrollment; and 4) understand challenges enrollees face choosing and using insurance benefits and the types of information and tools needed during and after enrollment. We will use a longitudinal design to follow a cohort of individuals and families enrolling in non- group plans from a large insurance carrier in and outside health insurance exchanges during 2017 open enrollment in four New England states. We will gather baseline survey data about enrollee characteristics and decision making tools used to choose the plan. After 12 months of enrollment, we will collect follow-up survey data about downstream outcomes, and obtain claims data on utilization and costs in the plan. The research team’s expertise in health policy, health services research, economics, and clinical medicine will foster a policy-relevant, scientifically rigorous R01 in an environment with a track record of academic research using health plan data and populations. This project provides a unique and timely opportunity to rigorously study the impact of unprecedented changes to the non-group insurance market on health plan decision making, access, and affordability. This project will provide crucial data for policy makers and health plans to inform the design of exchanges and decision support tools to enable consumers to choose high quality health insurance coverage that minimizes costs and promotes use of high-value health care.

Public health relevance
PROJECT NARRATIVE Health insurance exchanges created as part of health care reform have the potential to assist consumers in navigating the complex array of options for purchasing coverage on their own in the non-group health insurance market. As states continue to refine the design of their exchanges and develop decision support tools for consumers, this study will provide answers to crucial scientific and policy questions about health plan decision making and downstream access to health care and affordability in non-group plans in and outside exchanges. Findings from the proposed project will guide policy makers, health plans, and consumers in their efforts to improve access to affordable, quality health insurance and health care.